Disrupting Tuberculosis Transmission: Bacterial and Host Drivers of Mycobacterium Tuberculosis Aerosolization

Project Abstract
The global tuberculosis (TB) epidemic is fueled by the airborne transmission of Mycobacterium tuberculosis
(Mtb), yet the mechanisms underlying cough-mediated aerosolization and the impact of antibiotic treatment and
drug resistance on transmission remain poorly understood. We propose to address these gaps using ex vivo
cultured nociceptive neurons and a guinea pig model of human cough to investigate the role of host and bacterial
factors in TB transmission and evaluate strategies to disrupt this process. Preliminary data show that Mtb
glycolipids, sulfolipid-1 (SL-1) and phenolic glycolipid (PGL), activate nociceptive neurons and drive the cough
reflex, a critical driver of Mtb aerosolization and person-to-person transmission. Leveraging our innovative
nociceptive neuron activation model and Mtb cough measurement and particle capture systems we developed
specifically to study Mtb aerobiology, this project will uncover the drivers of Mtb transmission and explore
interventions to mitigate it. In the first aim, we will analyze how biological sex, antibiotic treatment, and drug
resistance influence Mtb-induced cough and Mtb aerosol production. By comparing male and female guinea
pigs, we will determine the impact of host sex on cough frequency and Mtb aerosol generation. We will also
evaluate how standard (rifampin-isoniazide-pyrazinamide; RIP) and newer (bedaquiline-pretomanid-linezolid;
BPaL) antibiotic regimens reduce cough and Mtb aerosol production and test whether drug-resistant Mtb strains
alter these processes, potentially enhancing transmissibility. The second aim will focus on cough suppression as
a host-directed intervention. Using inhibitors of nociceptive neuron pathways, we will evaluate their ability to
reduce Mtb-induced neuronal activation, cough and infectious particle production. These studies will test whether
blocking the cough reflex has potential to mitigate Mtb transmission.

Public health relevance
Project Narrative Tuberculosis (TB) is a leading cause of death worldwide, driven by the airborne transmission of Mycobacterium tuberculosis (Mtb). This project seeks to understand how bacterial factors, such as glycolipids, and host factors, such as airway nociceptive neuron activation, influence cough—a critical mechanism for Mtb aerosolization and spread. Using an innovative guinea pig model of human cough, we will examine how antibiotic treatment and drug resistance affect cough and Mtb containing particle production. We will also test the potential of cough inhibitors as a novel intervention to reduce Mtb transmission. By uncovering the mechanisms that drive Mtb transmission through cough and exploring strategies to block its spread, this work aims to inform TB control policies and reduce its global burden.